Michigan Lupus Epidemiology & Surveillance (MILES) Program Longitudinal Cohort

DESCRIPTION (provided by applicant): Project Summary/Abstract This proposal is to extend the Michigan Lupus Epidemiology & Surveillance (MILES) Program beyond the nearly completed public health surveillance phase to a research phase, by creating and maintaining the MILES Longitudinal Cohort & Biobank, which will include both lupus cases from the existing surveillance registry and population-based controls. The overarching goal will be to prospectively collect data and biospecimens that will allow for comprehensive investigations related to the clinical course of lupus, including risk factors for both the onset and progression of disease and its comorbidities. Detailed data collection for all participants will include a number of measures related to sociodemographics, health/wellness, physical functioning, environmental exposures, genetics, and for female participants, a number of items related to women's health. Lupus-specific measures, including disease activity indices, will be assessed for the SLE patients. The biobank will include serum, plasma, PBMCs, DNA (isolated both from unfractionated PBMCs and lymphocyte subsets), hair and toenail clippings. Vaginal swabs for female participants of reproductive age will be collected, allowing for HPV DNA profiling. Three distinct research modules related to lupus etiology and comorbidities are integrated, with the topics specifically dealing with epigenetics, HPV infection, and centrally-mediated pain. Biobank specimens will be stored in appropriate conditions to allow for genotyping and future investigation of biomarkers of both disease and exposure. An emphasis will be placed on providing the capability to perform contemporary immunoassays, including DNA methylation of relevant lymphocyte subsets. Lastly, this proposal will support the performance of single nucleotide polymorphisms (SNP) genotyping using the ImmunoChip. The MILES Cohort will thus serve as a robust platform for ongoing and future research investigations that are relevant to the full spectrum of lupus and its complications.

Public health relevance
Project Narrative Lupus is a serious and potentially fatal autoimmune condition, which disproportionately affects women and minorities. This population-based cohort and biobank will prospectively follow participants from the general population, with particular emphasis on inclusion of minorities and persons from underserved communities, in order to learn more about the disease and related health disparities. __SpecificAimsTextDelimiter__ Michigan Lupus Epidemiology & Surveillance (MILES) Program Longitudinal Cohort The overarching goal of the MILES Longitudinal Cohort is to prospectively collect data and biospecimens that will allow for comprehensive investigations related to the clinical course of lupus, including risk factors for both the onset and progression of disease and its comorbidities. The MILES Longitudinal Cohort will facilitate clinical, translational, and epidemiological research, by maintaining active follow-up of a large, diverse, and well-characterized population-based cohort of lupus patients and controls who have explicitly agreed to be followed longitudinally and contacted about future ancillary research studies. The Cohort will thus serve as a robust platform for ongoing and future research investigations that are relevant to the full spectrum of lupus and its complications. Specific Aims of the MILES Longitudinal Cohort & Biobank 1 To recruit and retain a study population of lupus patients from the MILES Program Registry, and population-based controls, as participants in a longitudinal research cohort that will be reasonably representative of the general population in the United States 2 To engage with the communities in southeastern Michigan that will be served by the MILES Program, in order to promote awareness and understanding of lupus and the research being conducted 3 To create and maintain a biobank of specimens from the lupus patients and controls, to create the capacity to investigate both standard biomarkers and genotyping assays, as well as more novel biomarkers related to the immune system and immunotoxicity 4 To systematically collect and analyze detailed sociodemographic, clinical, epidemiological, genetic, environmental, quality of life, healthcare access/utilization and outcomes data, in order to enhance understanding of risk factors for lupus and disease progression, as well as the public health impact 5 To capture data and specimens to support a broad array of future collaborative research, as well as to perform specific, high-impact investigations during the course of this grant period that leverage local resources and expertise. These novel areas of research will include the following distinct modules: ¿ Epigenetics and lupus - Examination of DNA methylation patterns in CD4+ T cell subsets in lupus patients and controls, and to examine the relationships between global and gene-specific DNA methylation, exposure to immunotoxicants, lupus activity and immunosuppressive therapy ¿ HPV and lupus - Comparison of the incidence, prevalence and clearance rates of 13 "high-risk" oncogenic HPV subtypes in female lupus patients versus controls over a 5 year period, and to determine within lupus patients how treatment with immunosuppressives impacts clearance rates ¿ Pain in lupus - Characterization of the prevalence and impact of pain, fatigue, and memory difficulties that are due to non-inflammatory, central nervous system (CNS) mediated mechanisms, in lupus. While the modules purposefully address separate and important questions that can be investigated in parallel during the course of the grant period, they each relate to problems ultimately stemming from the unknown etiology of lupus, which in turn has precluded effective prevention and treatment strategies. The Epigenetics module attempts to yield insight into the etiology of lupus, which in turn could lead to prevention measures and the design of targeted therapies that would have improved efficacy and side effect profiles. The HPV and Pain modules address aspects related to inadequacies of current treatment paradigms (immunosuppression- associated risk of HPV-related comorbidities and failure to control non-inflammatory pain). The MILES Longitudinal Cohort will catalyze research in a transformative manner by deploying an unparalleled combination of locally accessible resources and expertise toward the common goal of deciphering the epidemiology and pathogenesis of lupus.